Adapting an Evidence-Based Program that Improves Oral Hygiene and Health for Assisted Living Residents with Dementia

Project Summary/Abstract
It could be said that many dementia care and caregiver support interventions are too limited, focusing solely on
psychosocial and behavioral issues. These issues are important, but so too is the physical health of people
with dementia -- especially because they are living longer and require even more support with health care and
activities of daily living. Just imagine the benefit of a physical health care intervention provided daily.
Case in point: tooth brushing, flossing, and gum and denture care. Many people with dementia resist mouth
care – almost 90% in nursing homes, in fact. As a result, only 16% have their teeth brushed regularly, putting
them at risk for aspiration pneumonia when they inhale bacteria from their teeth, tongue, and gums. In 2013,
the research team submitting this proposal developed one of the two existing dementia-focused mouth care
programs for nursing homes -- Mouth Care Without a Battle (MCWB) -- which already has become a standard
of nursing home care. MCWB changes caregivers' attitudes and behavior, improves oral health, and in a
cluster randomized trial, MCWB provided by nursing assistants reduced pneumonia incidence by 32 percent.
The next frontier is to extend MCWB to assisted living (AL), the primary long-term residential care provider for
persons with dementia. There are 30,200 AL communities across the country. As many as 90% of the 835,200
AL residents have cognitive impairment, and 42% have moderate or severe dementia (and on average, five
untreated oral health conditions/person), meaning MCWB has the potential to improve the health and quality of
life of more than 350,000 AL residents with dementia annually. There is a unique and timely opportunity to
transform MCWB for AL, given the North Carolina Department of Health and Human Services (DHHS) Special
Care Dentistry Program's partnership in this effort.
This nested cohort cluster randomized trial will apply the NIH Stage Model and principles of the Science of
Behavior Change to lay the groundwork for a pragmatic trial and real-world implementation of MCWB for AL
residents with dementia and their caregivers. The aims are to refine MCWB for AL, and examine research
efficacy (working with a research dental hygienist) and real-world efficacy (working with community public
health dental hygienists) to train personal care aides in 48 AL communities across North Carolina to provide
mouth care; the project will include 720 residents with dementia, 348 AL staff, and 24 dental hygienists.
Evaluation will address (1) the reach of the intervention; (2) effects on mediators/targets of change at the
organizational and individual level; (3) outcomes (oral hygiene, pneumonia, hospitalizations); (4) associations
between change at the organizational and individual level and outcomes, and also associations with
characteristics of the AL community and staff; and (5) attitudes, barriers, and facilitators.
By the conclusion of this project, MCWB will be ready for evaluation in a pragmatic trial of AL residents with
dementia and the staff who provide their care.

Public health relevance
Project Narrative This project will modify a program that reduces pneumonia among nursing home residents with dementia, so that it is appropriate for assisted living residents with dementia. The program provides daily mouth care to reduce bacteria in the mouth that lead to aspiration pneumonia. The project will develop methods that can be taught to assisted living providers by community dental hygienists, and that are ready for evaluation in a pragmatic trial of AL residents with dementia and the staff who provide their care.